Mapping ductal carcinoma in situ in space and time to reveal biomarkers that can predict invasive risk

ABSTRACT
Each year, 50.000 women are diagnosed with ductal carcinoma in situ (DCIS) in the US. DCIS is a non-invasive
form of breast cancer, which respects the natural tissue barriers of the breast, and is therefore not life-
threatening. However, some of these DCIS lesions overrule natural tissue barriers imposed by healthy breast
tissue, leading to invasive and metastatic breast cancer (IBC), a life-threatening disease. There is currently no
way to predict which DCIS will progress into IBC, causing all women diagnosed with DCIS to be treated with
invasive surgery and systemic therapy, causing overtreatment, harmful side effects, and psychological burden,
while also using valuable resources in healthcare systems. One of the caveats of clinical DCIS research is the
natural progression, which cannot be followed over time, as almost all patients are treated with surgical excision
when a lesion is detected. Therefore, the dynamics and natural course of DCIS growth and invasive
transformation remain poorly understood. To resolve this lack of dynamic information, PI Scheele at VIB, together
with collaborating labs at the Netherlands Cancer Institute, has developed the first living biobank of >100 patient-
derived xenograft (PDX) models of DCIS directly derived from human samples through orthotopic injections.
This biobank is a full representation of the patient population, and represents all DCIS molecular subtypes,
morphological growth patterns, histological features and grade, with high concordance with the original patient
samples. PI Scheele’s team also developed a way to analyze DCIS progression using a 3D whole-gland imaging
technique to study lesion size, location, and growth pattern in the intact tissues to better assess the growth
pattern of the different lesions. Using this approach, the team has shown that 3D growth pattern provides a much
better prediction for invasive progression than the classical markers derived from 2D histopathology. The VIB
team has identified that all DCIS lesions can be classified into two distinct 3D growth patterns: replacement
growth and expansive growth. Only the expansive growth pattern strongly correlates with invasion, whereas
replacement lesions never progress into invasive disease. However, the mechanisms by which one growth
pattern progresses into invasive breast cancer, whereas the other growth pattern remains indolent remain
unknown. Additionally, it is uncertain if these PDX derived growth patterns occur in patient samples, and whether
histological analysis will allow to identify these growth patterns. PI Scheele proposes to assess these
uncertainties and to further investigate the growth patterns of DCIS by understanding how DCIS cells can
overrule the natural barriers imposed by healthy breast tissue. Using the unique cohort of DCIS-PDX models,
combined with optical barcoding, 3D imaging and longitudinal (intravital) microscopy, the VIB team aims to build
detailed spatio-temporal (xyzt) maps of DCIS growth and progression. From these 4D maps of DCIS growth and
progression, the team aims to extract predictive biomarkers, such as morphological features or marker gene
expression, that can discriminate low-risk from high-risk DCIS prior to invasion in clinical pathology practice.

Public health relevance
NARRATIVE Each year, 50,000 women are diagnosed with ductal carcinoma in situ (DCIS) in the US; and although DCIS is classified as non-invasive, some DCIS will progress to invasive breast cancer. Currently, it is impossible to predict this progression meaning all DCIS patients are treated with the same invasive therapy, causing thousands of women with DCIS to be overtreated and undergo surgery and therapy they do not need. These overtreatment measures risk harmful side effects and add a significant psychological burden to patients, while using valuable resources in healthcare systems. This project aims to identify biomarkers to predict whether DCIS stays non-invasive or becomes invasive and life-threatening by studying the dynamic behavior of DCIS cells using advanced microscopy technologies and labelling techniques.